Cellular mechanisms by which Neisseria gonorrhoeae infects the female reproductive tract

Project Summary
Sexually transmitted infections (STIs) are a major public health challenge and a serious women's health issue,
as women can suffer severe complications from these infections: pelvic inflammatory disease (PID), infertility,
and predisposition to life-threatening ectopic pregnancy. However, the majority of these infections in the female
reproductive tract (FRT) are asymptomatic. How infection in the FRT causes such a wide range of clinical
outcomes in the absence of symptoms remains unknown. The primary obstacle to understanding STIs of the
FRT is the lack of a model that reasonably mimics all aspects of human infection. The cervix is the initiation
site for STIs in the FRT. The cervical mucosa is not uniform, composed of multilayered non-polarized
squamous epithelial cells at the ectocervix, a single layer of polarized columnar cells at the endocervix, and the
progressively changing epithelia in the transformation zone. While tissue culture models have contributed
significantly to explaining specific host-pathogen interactions, how STI pathogens deal with different epithelia
for infection is unclear, as no cell culture model can mimic the varying mucosal surfaces of the human cervix.
To overcome these obstacles, we are developing a new infection model using human cervical tissue explants
to address our long-term goal: to delineate the mechanisms by which STI pathogens infect the FRT.
To pursue this goal, this proposal focuses on the cellular mechanism by which Neisseria gonorrhoeae (GC)
modulates the infection process in the human cervix. GC causes gonorrhea that is the second most common
STI and a public health crisis worldwide due to the upsurge of multi-drug resistant GC. The surface molecules
of GC undergo phase variation, which has been implicated in its broad infection outcomes. We hypothesize
that the expression of pili and distinct variants of opacity associated proteins (Opa) allows for changes
in GC infectivity, while the properties of epithelial cells of the human cervix determine which regions
are vulnerable to GC infections. To test the hypothesis, we will use our human cervical tissue model and
isogenic strains of GC that express invariable Opas and pili to define the cellular mechanism by which pili and
Opa phase variation and the distinct properties of cervical epithelial cells regulate GC infection in the FRT.
Our cervical explant model breaks a major barrier of the field, making it possible for the first time to
examine cellular events occurring during GC infection to their in vivo targeted epithelial cells under a
physiologically relevant environment. These studies will reveal new mechanisms that can finally explain how
GC manipulate signaling and cytoskeleton based on their surface molecules and the type of epithelial cells with
which they interact to switch the cervical infection between colonizing and penetrating nature. The new tissue
model and infection mechanisms established by this project may fundamentally change our way to pursue the
understanding of STIs and open new avenues for interventive drug designs for the prevention of STIs.

Public health relevance
Project Narrative This project examines the cellular mechanisms by which Neisseria gonorrhoeae infects the female reproductive tract to cause gonorrhea, one of the most common sexually transmitted diseases. The results of this project will significantly expand our mechanistic understanding of how sexually transmitted pathogens manipulate host cells in the human cervix to infect and cause different complications in women. It will also open new avenues for preventative and therapeutic designs for gonorrhea and other sexually transmitted infections in women, addressing the threat of the emergence of antibiotic-resistance N. gonorrhoeae.